EFFECT OF BILE ON PANCREATIC ENZYME SURVIVAL DURING SMALL BOWEL TRANSIT

To learn what effect infusing nutrients into the stomach and intestine has on secretion of pancreatic enzymes and movement of food through the upper small intestine in healthy subjects.